Elucidating the mechanism of amyloid-beta's pathological aggregation

Project summary/Abstract Alzheimer’s disease (AD), the most common neurodegenerative disorder, is an age-dependent disorder resulting in progressive loss of cognitive function. It affects more than 4 million people in the United States and is therefore a highly relevant factor in the elderly’s quality of life. The symptoms of the disease strongly correlate with the presence of transiently formed and soluble aggregates of amyloid-B (AB) in the brains of AD patients. Because of the relevance Alzheimer’s to public health, there is substantial interest in understanding the molecular mechanism of AD and treating the disease. Nevertheless, the short-lived nature of the AB soluble intermediates formed during the course of its pathological aggregation presents a formidable challenge to the traditional techniques used for the investigation of biological molecules. Although progress has been made in studying these molecules, by making slight chemical modifications that increase their stability, for example, it is not known whether the molecular behavior observed in these studies is completely relevant to the behavior of AB in humans. In the Frydman lab techniques have been developed that allow the fast characterization of features of biological molecules relevant to their behavior (structure and dynamics). We propose to use these techniques, a suite of ultrafast NMR experiments, to investigate the structure and dynamics of AB as it undergoes aggregation. Ultrafast TOCSY and STD-TOCSY experiments will be used to probe the interaction between AB monomers and oligomers during the aggregation process. The diffusive dynamics of the system will be probed by ultrafast DOSY experiments, which separates resonances according to the hydrodynamic radii associated with the chemical sites to which they belong. Further functional insights will also be gained from site-resolved longitudinal relaxation measurements, which reveal the mobility of molecular fragments¿and hence their degree of polymerization. This proposal aims to uncover detailed structural information about AB’s folded monomeric state, which is believed to play a crucial role in the formation of a nucleus for AB’s aggregation. In aqueous solution, folded conformers of AB undergo conformational exchange with its random coil state. Using the innovative selective dynamic recoupling (SDR) technique that I have developed, the chemical shifts of folded AB conformers will be revealed, which can be used to probe their structures. The in vivo behavior of AB in a cellular environment is believed to play a significant role in its pathology. I plan to uncover detailed information on the intracellular behavior of AB by performing NMR experiments in living Xenopus laevis oocytes.

Public health relevance
Alzheimer’s disease (AD), the most common neurodegenerative disorder, is an age dependent disorder resulting in progressive loss of cognitive function. It carries an estimated annual burden of over 100 billion dollars in the United States when caregiver’s medical expenses and lost productivity are included.